Enhancement of the HIV Antibody Database tool for Open Science

Project Summary The goal of our P01 HIVRAD Project is to advance our germline-targeting approach to HIV-1 vaccine design by cycles of immunogen design and testing in transgenic mice and macaques. The experiments proposed in this P01 grant will produce candidate immunogens for testing in macaques by collaborator Dr. Malcolm Martin and for vaccine trials in humans. One innovative aspect of the project is its integrated approach to structure determination and immunogen design, selection, and evaluation - the same people solving structures are also involved with immunogen design and screening, allowing a rapid and informed cycle of iterative improvements of immunogens. As part of this integrated approach, the Bjorkman lab has developed the software package HIV Antibody Database, which was designed to enable frictionless access to, comparisons of, and analyses of broadly neutralizing anti-HIV antibody sequences, structures, and neutralization data. This program includes a data analysis tool to identify HIV-1 Env sequence features responsible for neutralization/binding potency variability across strains. This innovative tool has allowed us to determine key interactions at Ab/Env interfaces using a combination of structural and bioinformatics analyses. We propose to enhance the HIV Antibody Database tool by improving its robustness and sustainability by integrating publicly available data streams, adopting standard formats for input and output of structural data, optimizing performance, and integrating another program developed by the Bjorkman lab, Variant Database, which can query a viral mutational landscape. Variant Database can quickly search SARS-CoV-2 genome datasets with over a million sequences. Thus, it can be used to detect emerging mutation patterns that might be overlooked in conventional phylogenetic analyses. We propose to generalize Variant Database to analyze different virus taxa, including HIV-1. Variant Database will be enhanced to be more robust and sustainable, and this version will be integrated with HIV Antibody Database.

Public health relevance
Project Narrative HIV/AIDS remains an important threat to global public health; at least 60 million people have been infected with HIV-1, of which almost half have died. Building upon our knowledge of the structural correlates of antibody neutralization of HIV-1, we are using immunogen design, selection, and evaluation schemes to raise broad and potent neutralizing antibodies in animal models that is directly relevant to vaccine efforts in humans. We propose to enhance our software tool HIV Antibody Database to improve its utility, software quality, and useability by integrating publicly available data, adopting standard formats for input, and providing better interoperability with other software.